Interventions to Reduce Infant Mortality and Morbidity in Low Resource Settings

Project Summary
This application provides evidence that the Principal and International Principal Investigators
leading the UAB-Zambia team have an established record of major accomplishments in the
Global Network, including the design, implementation, and publication of single site and
common protocol clinical trials and studies that led to major international and national guidelines
and improved care practices. The UAB-Zambia team has access to a stable set of
geographically distinct rural clusters and urban delivery facilities where the team has conducted
research over the last 19 years. The international partner, University Teaching
Hospital/University of Zambia, and a multi-disciplinary team consisting of specialists in
obstetrics, pediatrics, and public health in Lusaka, Zambia have collaborated in research,
training, education, and implementation/scale-up of state-of-the-art research targeted to the
most common causes of maternal and neonatal/infant/child mortality and severe morbidities.
The exceptional organizational capabilities and local support facilitate full participation in all
Global Network trials and studies, including high recruitment and over 99% follow-up rates. The
administrative teams at UAB and Zambia provide all the necessary support for the success of all
grant activities. All Zambian staff members have a record of excellent performance and
accomplishments in the Network, including most working with the team since the first cycle of
the Global Network. The proposed team of investigators have collaborated for over 19 years
and will continue to work with the NICHD and other sites of the Global Network to lead
innovative and impactful randomized trials and observational studies that transform the care of
mothers and infants. The UAB-Zambia team has designed major transformative studies
including the FIRST BREATH, BRAIN-HIT, and A-PLUS trials as well as the Predictive Modeling
for Perinatal Mortality in Resource-Limited Settings database study. The qualifications and
unequivocal commitment of the investigators the Zambian staff, as well as the full endorsement
of the Government of Zambia, University Teaching Hospital (Zambia), University of Zambia, and
the University of Alabama at Birmingham will ensure superior performance if this site is granted
participation in the Network. The long-term objective is to improve local health care systems
with education, training, research, implementation, and sustainability of programs to decrease
preventable maternal and child mortality and morbidities.

Public health relevance
Project Narrative Continued high rates of neonatal, infant, child, and maternal mortality and severe morbidities require a concerted effort of effective domestic and international partners to improve healthcare in resource-limited settings. This grant application will allow the top performing UAB-Zambia team participation in the Global Network to continue to lead transformational research that changes international guidelines for maternal and child care and reduce adverse pregnancy and child outcomes.